Glycogen synthase kinase 3 ligand discovery for Alzheimer’s disease

Project Summary. Glycogen synthase kinase 3 (GSK3) is considered a key player in the pathophysiology of
Alzheimer’s disease (AD) since dysregulation of this enzyme influences all the major AD hallmarks, including tau
phosphorylation, amyloid-β production, neurogenesis, inflammation and synaptic function. Therefore pharmacological
modulation of GSK3 represents an attractive therapeutic approach for the treatment of AD. Positron emission
tomography (PET) is capable of quantifying biochemical processes in vivo, and a suitable GSK3 ligand would
substantially improve our understanding of GSK3-mediated signaling pathway under different pathophysiological AD
conditions, otherwise inaccessible by ex vivo (destructive) analysis. Quantification of GSK3 in living brain by PET
would provide the assessment of distribution, target engagement and dose occupancy of new GSK3-targeted
neurotherapeutics. To date, no successful examples have been demonstrated to image GSK3 in human for drug
discovery and clinical use, representing a significant deficiency of our ability to study this target in vivo. Therefore, we
propose to develop a novel PET ligand that can fill this void, as the first translational imaging tool.
We are the first groups to develop GSK3-specific ligands in cross-species PET studies, including the first selective
ligand [11C]PF-367. However, this ligand was discontinued due to low-to-moderate brain uptake and marginal binding
specificity in vivo. In our 2nd generation, we identified a lead molecule, GSK3-817, which showed high binding affinity
and excellent selectivity. An 18F-isotopologue of GSK3-817 was synthesized and preliminary PET imaging studies
confirmed that we have overcome two major obstacles for GSK3-specific kinase ligand development by achieving: 1)
substantially-improved brain penetration (≥1 SUV brain uptake) and 2) reasonable target specificity. Though GSK3-
817 is a promising lead molecule for the development of new GSK3-targeted PET ligands, further optimization for
improved binding specificity and proper brain kinetics are sought for translational cross-species (rodents and
nonhuman primates) imaging studies to achieve optimal GSK3 quantification for drug discovery and clinical translation
for AD patients.
On the basis that GSK3-817 serves a validated lead for medicinal chemistry optimization, as specific goals, we
will design and prepare a focused library of GSK3-specific modulators amenable for labeling with 11C or 18F (preferred),
and evaluate their ability to quantify GSK3 expression and changes during drug challenge in rodents and nonhuman
primates, as well as autoradiography and biological validation in postmortem human brain tissues. The impact of this
work is not only to develop the first successful highly-specific GSK3 PET ligand for the study of neurodegenerative
disease-related biological processes, but also ultimately, via PET imaging validation in higher species, to advance
this ligand for potential clinical translation and monitor target response of novel neurotherapeutics for
neurodegenerative diseases, including AD.

Public health relevance
Project Narrative As the burden of Alzheimer’s disease in the United States and worldwide is high, there is a critical need to develop novel chemical ligands to image illness-related biological processes in the brain. This work will develop key imaging tools to advance the scientific understanding of GSK3-based altered neuroimmune function and its role in the pathophysiology of Alzheimer’s disease, facilitating the discovery of novel AD neurotherapeutics.